Neuropathology Core

The Neuropathology Core (NPC) fulfills several important roles within the
University of Pittsburgh ADRC (PITT-ADRC). Postmortem neuropathological confirmation of the clinical
diagnosis of Alzheimer’s disease (AD) and related disorders and the assessment of co-existing
neurodegenerative and vascular disease processes is essential to promote progress in diagnosis, treatment and
prevention of AD. Since its inception, the NPC has collected and characterized 868 brains from PITT-ADRC
subjects at various disease stages. This resource has been extensively utilized for teaching purposes and for
research studies by local and national investigators to develop amyloid PET imaging agents and correlate in vivo
amyloid imaging results with postmortem findings, improve our understanding of genetic factors contributing to
AD risk and advance our knowledge regarding the neurobiology of psychiatric comorbidities and
neuroinflammatory processes.
Our proposed approach to fulfill the diagnostic, tissue banking, research and educational roles of the NPC is
outlined in five specific aims: 1) The NPC will continue to maintain and expand a well-catalogued bank of brain
tissue samples and fibroblasts of ADRC participants and subjects from affiliated cohorts. A special emphasis will
be placed on harvesting brains from subjects with premortem PiB and tau PET imaging studies and perform
post-mortem 7T MRI on a select group of participants. 2) All banked cases undergo detailed diagnostic
evaluation using the latest consensus criteria and detailed characterization of comorbid and aging-related
pathologies. Results will be shared with ADRC clinical staff, families and uploaded to local and national
databases (NACC). 3) The NPC will develop, implement and refine novel methods for postmortem tissue
characterization such as postmortem MR imaging and digital image analysis algorithms for radiological-to-
pathological alignments, quantification of pathology burden and creation of pathology endophenotypes. 4) The
NPC will participate in local and national research efforts by providing brain bank tissue materials and
neuropathology data from diagnostic evaluations. The NPC will closely collaborate with other PITT-ADRC cores
and projects in joint research studies and will engage in NPC-driven research projects. 5) In collaboration with
the Research Education Component, the NPC will leverage brain bank materials and expertise to educate
neuropathology fellows, residents, medical students and investigators about the neuropathologic features of
neurodegenerative diseases.
Through these aims, the NPC will provide precise diagnostic classifications of PITT-ADRC research
participants, enable studies of phenotype variations and broadly support efforts to improve our understanding of
the underlying disease processes.
Neuropathology Core Abstract: